Identification of serum protein biomarkers by profiling N-glycoproteomes of patient-derived xenografts of neuroendocrine prostate cancer

PROJECT SUMMARY
Neuroendocrine prostate cancer (NEPC) is a lethal variant of prostate cancer (PCa) that may arise de
novo or in 17-30% of patients previously treated with standard of care androgen deprivation therapy (ADT) for
prostate adenocarcinoma (AC) as a mechanism of resistance. Serum biomarkers with high sensitivity and
specificity for non-invasive detection for NEPC are urgently needed to enable clinicians to select the proper
next-line systemic therapy in a timely manner, select of patients for clinical trials, and monitor treatment
responses that entail reversing the NEPC state. A novel strategy that allows quick identification of ‘‘human-
unique’’ proteins in a mouse serum background, thereby overcoming limitations associated with proteomics-
based biomarker discovery, has been used successfully to identify serum glycoprotein biomarkers in ovarian
cancer patient-derived xenografts (PDX). We hypothesize that PCa PDX tumors that reflect human PCa
express unique tumor-associated glycoproteins that can be readily identified in sera of tumor-bearing mice
using mass spectrometry. Moreover, different serum glycoproteins and their levels are associated with different
subtypes of PCa PDXs, namely, pure AC, AC mixed with NEPC, and pure NEPC. Finally, these subtype
specific biomarkers can be used to identify NEPC in clinical samples from PCa patients.
In Aim 1, we will identify novel serum glycoproteins associated with subtypes of PCa PDX tumors by
glycoproteomic analyses of PDX sera. Specifically, PDX tumors will be generated using cryopreserved tissues
from publically available PDXs lines with pure AC, AC mixed with NEPC and pure NEPC histology by subrenal
implantation into immunodeficient mice. Quantitative proteomics will be performed to generate glycoproteomic
profiles of PDX sera and human-specific proteins will be selected bioinformatically. In Aim 2, serum proteins
found in samples with a NEPC component but not expressed in pure AC samples will be selected. The top 5
candidate NEPC-specific biomarkers for which a targeted assay is developed successfully will be validated in
sera from PDX mice and patients with pathologically confirmed NEPC component. The sensitivity and
specificity of these biomarkers will be assessed using sera from patients with pathologically confirmed AC and
benign prostatic hyperplasia as true negative control.
Our approach would lead to biomarkers that could be developed quickly for use in the clinic to reduce
morbid biopsies and appropriately triage patients to therapies tailored to their disease state, which in turn, will
improve quality of life and survival. In addition, these biomarkers could be used to monitor patient response to
standard-of-care therapies and select patients for clinical trials testing novel therapies developed in the future
that target NEPC specifically. Moreover, the subtype-specific glycoproteins we identified could serve as the
basis for future imaging strategies or targeted therapies. Finally, the glycoproteomes of NEPC will provide a
valuable resource for better understanding the mechanisms of NEPC development.

Public health relevance
PROJECT NARRATIVE Compared to biopsies, serum biomarker measurements eliminate invasive procedures to patients, are less expensive and most importantly, may help identify neuroendocrine prostate cancer (PCa), a lethal variant of PCa, earlier so that new therapies can be started in a timely manner. N-glycoproteomic analyses of sera from patient-derived xenografts (PDXs) represent a new paradigm of protein biomarker discovery that overcomes the most challenging limitation of proteomic profiling based approaches. In this proposal, we will identify human-specific N-glycosylated proteins in a mouse background with high sensitivity using PCa PDX models and validate potential biomarkers associated with tumor volume in PCa patient sera.